Cell-cell communication mediated by fluid flows

Project Summary
Cells can detect external fluid flows across their surface. Such flows, and the flow signaling events they induce,
are critical for organ development, homeostasis, cancer dissemination, and host-microbe interactions, yet we
know little about how cells sense and respond to their hydrodynamic environment. This research program aims
to reveal fundamental mechanisms by which cells communicate through fluid flows. Specifically, we investigate
how cells generate and sense fluid flows, and how sensory cells respond to flow-derived signals. To generate
new fundamental knowledge about flow signaling, we use the well-established and highly tractable left-right
patterning system of zebrafish embryos. In this system, which is amenable to genetic perturbation as well as
high-resolution and quantitative imaging, a flow signal represses the expression of a key target gene, dand5, in
sensory cells. In our prior work, we discovered that Pkd1l1, a large Polycystin membrane protein, is critical for
flow-induced dand5 repression. In one aspect of our proposed work, we will test our hypothesis that Pkd1l1 is
a flow signal sensory component by determining the cell types, as well as sub-cellular site of action, in which
Pkd1l1 functions downstream of flow signals. We also investigate the functional role of mechanosensitive
domains within Pkd1l1 in flow-regulated signaling. In a second project, we address the major gap in
understanding of how flow signals are transduced within sensory cells. This work will use our optimized
CRISPR approaches to discover and validate new flow signal transduction machinery, something which will
markedly expand our understanding of the mechanisms acting downstream of sensory events to transduce
signals intracellularly. In a third project, we will use the known post-transcriptional repression of dand5 that
occurs specifically on the left side downstream of the flow signal as a model for generating new knowledge of
how sensory cells respond to flow signals. This includes determining the role of the 3’untranslated region and
how RNA-binding proteins and microRNAs act downstream of flow signals to repress gene expression. This
work will be aided by novel in vivo reporters we are developing which quantify flow signaling pathway outputs.
Overall, this research will uncover novel mechanisms by which cells communicate through flow signals. While
chemical signal transduction cascades (Hedgehog, Wnt, etc.) are widely studied, flow signaling pathways
represent a new frontier, with many fundamental principles waiting to be discovered. Our work using the highly
tractable left-right patterning system of zebrafish will reveal new principles of flow signal sensation and
transduction, as well as how cells respond to flow signals. Since aberrant flow signals occur in many disease
states, this will open new opportunities to improve human health.

Public health relevance
Project Narrative Fluid flows over the external surface of cells serve as sources of information during cell-cell communication events, but how cells sense and respond to flow-derived signals is not understood. We propose to use the tractable zebrafish left-right patterning system to determine fundamental mechanisms by which cells generate, sense and interpret fluid flows using advanced genetic and imaging approaches. Since abnormal flows occur in a range of diseases, our work promises new opportunities for improving human health.